Administrative Core

The UIUC Neuroproteomics and Neurometabolomics Center on Cell-Cell Signaling provides high-end 'omics-
scale characterization of the small molecules, peptides, and proteins in samples obtained from brain sub-regions
such as defined nuclei and even specific single cells. The Center also develops innovative measurement and
analysis technologies and provides these advanced toolsets to both the NIDA-specific and broader neuroscience
research communities. The Center is organized under the umbrella of this Administrative Core and includes
three research cores, Sampling and Separation, Molecular Profiling and Characterization, and Bioinformatics,
Data Analytics and Predictive Modeling, and our Pilot Research Project Core, as well as internal and external
advisory groups. Tasked with ensuring the seamless operation of the Center, this core facilitates the flow of
information between the research cores, our biological user base, and the advisory teams. The Administrative
Core monitors compliance of our cores with our Data Management Plan and our Plan for Enhancing Diverse
Perspectives. In consultation with our internal advisory committee, the Administrative Core also evaluates
ongoing and potential user research projects, and identifies appropriate pilot projects. These evaluations are
used to terminate support for non-productive projects and select new users. The Administrative Core makes
certain that the Center runs smoothly and efficiently, particularly with regard to scheduling and resource
allocation, coordinates Center activities to achieve optimum productivity in supporting the users in our research
project base and in developing new technologies, helps the other cores disseminate our output widely to
appropriate scientific communities (such as the technology development and drug abuse research communities),
facilitates the training and education of our staff and user base as needed, and schedules presentations and
sessions related to Center activities at local and national meetings. The Administrative Core has successfully
implemented these responsibilities for over 19 years and will continue to provide the same level of support to
Center in the coming period. The high level of synergy between the neuroscientists and technologists affiliated
with the Center ensures we will continue to enable exciting scientific advances in understanding how systems of
neurons interact in both the healthy nervous system and upon exposure to drugs of abuse. Lastly, a series of
outreach initiatives enabled through this Core, combined with the Center’s extensive publication history,
guarantees that our protocols and approaches are made widely available to the appropriate scientific
communities.